Administrative Core

PROJECT SUMMARY (Administrative Core)
The Administrative Core will be the central hub of the proposed Harvard PRECISION Human Pain Center. It will
monitor milestone progress, organize regular meetings to facilitate troubleshooting and data sharing, monitor
oversight and feedback from the HEAL Steering Committee, oversee Center-wide budgetary, logistical, and
regulatory issues regarding tissue and data delivery between the Cores and other U19/U24 Centers. It will
administer a Center Slack channel to ensure investigators are connected in real-time as new patient/donor
samples become available and require downstream processing. It will also represent the Center at external
PRECISION Human Pain Network meetings and relay feedback from these meetings back to the Center. It will
also be responsible for external scientific communications including a Center website, interim reports, tool and
data dissemination.